Master regulator transcription factors promote esophageal neoplastic evolution

PROJECT SUMMARY
Esophageal adenocarcinoma (EAC) is one of the deadliest malignancies, and its incidence has strikingly
increased 6-8 fold in Western countries (including the United States, UK and several European countries)
over the past 4 decades. Despite new insights gained from recent genomic analyses, meaningful therapeutic
improvements have not occurred and the 5-year survival of EAC hasremained extremely low (~20%). Therefore,
alternative research approaches, including advanced epigenomic studies, are desperately needed to
understand the molecular basis of EAC for developing novel treatment regimens. Barrett’s esophagus (BE) is a
premalignant condition and is considered as the obligate precursor lesion of EAC. During Barrett’s esophagus-
associated neoplastic evolution, benign BE first becomes dysplastic and then progresses to EAC. Therefore,
BE serves as an ideal pre-malignant model for the investigation of the step-wise neoplastic evolution of
esophageal epithelial cells. However, our understanding of the molecular mechanisms promoting BEAN
remains limited, with key questions (e.g., the primary drivers for the malignant transformation of BE into EAC)
still unaddressed.
We and others have shown that malignant transformation is accompanied by genome-wide gains and
losses of enhancers and super-enhancers, which are occupied and regulated by upstream master regulator
transcription factors (MRTFs). Indeed, our recent studies demonstrated profound alterations in both enhancer
usage and MRTF activity between normal gastroesophageal junction (NGEJ), BE and EAC samples.
Particularly, we have identified a set of EAC-specific MRTFs (ELF3, KLF5, GATA6, EHF). Pilot experiments
have shown that these 4 MRTFs co-occupy hundreds of EAC- specific enhancers and super-enhancers,
indicating they may regulate the EAC transcriptome. Moreover, these EAC-specific MRTFs are highly and
uniquely expressed in EAC compared with normal GEJ or BE samples and are functionally required for EAC
cell proliferation.
Based on these findings, we hypothesize that EAC-specific MRTFs directly promote the malignant
transformation of BE cells by rewiring enhancers and super-enhancers across the epigenome, activating
signaling pathways and cellular processes essential for EAC development. We will test this hypothesis by
investigating the biological functions of MRTFs in human BE-derived 3D organoids. In addition, we will study
the mechanistic basis of the strong association between obesity and EAC by focusing on the regulatory loop
of MRTF and fatty-acid synthesis, which is the key downstream pathway identified by our preliminary data.
These investigations promise to establish primary driving forces of BE-associated neoplasia evolution and
uncover epigenomic mechanisms underlying esophagus transformation, which will fundamentally transform our
insights into the biology of esophageal cancer. More importantly, successful execution of this proposal may
identify potential avenue for the prevention and early intervention of EAC by targeting fatty-acid synthesis
pathway inthe high-risk individuals (e.g., refractory and/or high-grade BE patients) with obese condition.

Public health relevance
PROJECT NARRATIVE The incidence of esophageal adenocarcinoma (EAC), a deadly cancer, has risen rapidly in the United States. In this study, we will characterize the primary driving forces transforming Barrett’s esophagus into malignant EAC using advanced epigenomic approaches. Furthermore, we will investigate the mechanistic basis of the strong association between obesity and EAC. Our results hold the promise to fundamentally transform the understanding of neoplastic evolution of esophagus, while simultaneously discovering novel driver genes, pathways and potential actionable targets for EAC.